Effects of Vaccination on Acute and Post-Acute Respiratory Viral Infection Outcomes in Solid Organ Transplant Recipients

Project Summary/Abstract
Respiratory viral infections (RVI) including SARS-CoV-2, RSV, and influenza, are major threats to the health of
solid organ transplant recipients (SOTRs), who live at the intersection of chronic comorbidity, frailty, and heavy
immunosuppression. These factors contribute to high rates of clinically observed severe RVI and pose risks for
poorly understood post-acute syndromes including organ dysfunction and protracted infections associated with
immune evasive mutations of public/health/relevance. Furthermore, as starkly outlined during the COVID-19
pandemic, RVI vaccine immunogenicity and effectiveness are suboptimal in SOTRs, connoting ongoing risk for
adverse outcomes despite vaccination. Due to a lack of clinical trials of novel platforms in SOTRs, such as
variant-updated SARS-CoV-2 and RSV vaccines, robust prospective observational data are urgently needed.
In this proposal, we will leverage and expand the first national-scale prospective cohort of US SOTRs designed
to measure acute and post-acute RVI outcomes in the COVID-19-endemic era and assess real-world
immunoprotective effects of vaccination. Goals of this proposal include ascertainment of acute RVI events in a
large national cohort of SOTRs through asymptomatic and symptom-driven screening protocols to calculate
effectiveness of clinically-available vaccinations (Aim 1). Clinical and immunological associations with
breakthrough RVI in SOTRs post vaccination will then be assessed, including the role of longitudinal pathogenspecific plasma and mucosal immune responses (Aim 2). Additionally, the prevalence and phenotypes of postacute RVI sequela including “Long COVID” in SOTRs will be determined, including evaluation of potential
associations with persistent RVI shedding and evolution as well as vaccine-associated immune responses
(Aim 3). Taken together, this proposal will generate critical data on the contemporary burden of RVI among US
SOTRs, with particular focus on vaccine-preventable infections, to inform personalized risk calculations
incorporating clinical and mechanistic data. These findings will provide evidence base for further optimization
of immunoprophylactic interventions against acute and post-acute RVI complications among vulnerable
SOTRs in the COVID-19-endemic era.

Public health relevance
Project Narrative This proposal will develop the first national prospective cohort of US solid organ transplant recipients (SOTRs) to ascertain respiratory viral infections (RVIs) and assess the effectiveness of novel vaccinations on reducing acute and post-acute outcomes in the COVID-19-endemic era. The research will establish highest-risk SOTR phenotypes for RVI and associated morbidity, with focus on establishing immunological associations with breakthrough infection and protracted post-acute RVI syndromes. These data will identify SOTRs for whom additional interventions are needed to reduce RVI burden, including informing optimized approaches to immunoprophylaxis.